The first polymeric opioid conjugate vaccine

1. Abstract:
Opioid addiction is a national medical crisis that is expected to worsen due to the socioeconomic fallout caused by the
SARS-CoV-2 pandemic. Opioid vaccines are a promising treatment strategy for preventing opioid overdose and could
enhance drug treatment when combined with existing modalities. The aim of vaccination is to generate opioid-specific
antibodies (-opioid)s that bind to the drugs and sequester them in the serum, stopping opioids from entering the brain and
other organs, and thus preventing overdose and the sensation sought by the user. While monomeric opioid hapten conjugate
vaccines composed of opioid monomers conjugated to carrier proteins admixed with experimental adjuvants are efficacious
in rodents; the design of current monomeric opioid vaccines is based on monomeric vaccines for cocaine and nicotine that
generated relatively weak, short-lived antibody responses in humans. The goal of this proposal is to develop a polymeric
opioid conjugate vaccine that induces robust, long-lasting -opioid responses in the absence of toxicity. Durable antibody
responses are maintained by long-lived antibody-secreting cells (LLASCs), which are generated upon B cell activation in
the presence of B cell receptor (BCR) crosslinking, recognition of pathogen derived immunostimulatory signals, and
ligation of co-stimulatory signals from helper T cells. To elicit the signals necessary for opioid-specific B cell activation,
our polymeric opioid vaccine against fentanyl—the cause of most opioid overdose deaths—is composed of a water-soluble
copolymer that targets and activates fentanyl-specific B cells, termed p(Fent-co-TLR7), conjugated to the immunogenic
carrier protein tetanus toxin (TT) via a self-immolative linkage that, when cleaved, releases unmodified TT. We will
synthesize p(Fent-co-TLR7) as a random copolymer from a monomer decorated with fentanyl and a second monomer that
activates B cells via toll-like receptor 7 (TLR7). Thus, multivalent TT-p(Fent-co-TLR7) conjugates are designed to target
and crosslink opioid-specific B cell receptors (BCRs), causing B cell activation and BCR-mediated internalization. Once
internalized, TT-p(Fent-co-TLR7) will activate endosomal TLR7, amplifying B cell activation, and release TT. Once
released from p(Fent-co-TLR7) polymers, TT can be efficiently processed and its peptides presented on the surface of B
cells to TT-specific T cells, resulting in optimal T cell activation and the production of signals that drive B cells to
differentiate into LLASCs. In this proposal we will (1) optimize the formulation and demonstrate the mechanisms
responsible for the efficacy of TT-p(Fent-co-TLR7), (2) compare the immunogenicity and durability of the immune
response generated by TT-p(Fent-co-TLR7) to that of monomeric fentanyl-TT conjugate vaccines, and (3) demonstrate the
ability of TT-p(Fent-co-TLR7) to inhibit the behavior effects and lethality of fentanyl. Completion of this proposal will
validate the preclinical efficacy of a clinically-viable fentanyl vaccine and deliver a novel vaccine platform that can be
modified to treat the illicit use of other drugs as well as infectious diseases.

Public health relevance
Narrative: The opioid addiction crisis is responsible for over 150 deaths per day (CDC), and opioid vaccines, which elicit antibodies that bind opioids, preventing opioid passage into the brain, are a promising therapy for opioid use disorders. Although current experimental opioid conjugate vaccines are effective in rodents, the design of these vaccines is based on vaccines for cocaine and nicotine that generated short-lived immune responses in human trials. Here, we propose the development of a first-of-its-kind biomaterial- based opioid vaccine platform that is specifically designed to address the challenges that hamper current conjugate vaccines, and thus induce robust, durable, protective immunity against opioids.